Gain-of-function complement activators as a new class of immunotherapeutic molecules

SUMMARY
The complement system comprises over 30 proteins, mostly plasmatic, forming the oldest branch of the human
immune system. When activated by a pathogen, the complement system amplifies a loop that leads to the
destruction of the invading organism. Plasma and surface inhibitors tightly regulate complement activation to
prevent or limit self-damage. Unfortunately, gain-of-function (GOF) mutations in the complement activator factor
B (FB) found in some rare patients cause permanent complement activation that can lead to autoinflammation.
GOF-FB is more efficient at activating complement and is resistant to natural complement inhibitors. Given the
enhanced activity of these mutants, we hypothesize that we can redirect GOF-FB to target specific malignant
cells or tissues for therapeutic purposes and with minimal side effects. In this application, we propose generating
and testing in vitro molecules to direct GOF complement activating proteins specifically to cancer cells and solid
tumors. In Aim 1, we will fuse GOF-FB to single-chain variable antibody fragments (scFV) to direct complement
activation to specific cells or antigenic targets. This engineered biologic approach to target immunotherapy will
lead to less expensive and off-the-shelf alternatives to chimeric antigen receptor T cells (CAR-T) and be
immediately relevant for hematologic malignancies. These molecules could also overcome some of the current
issues with antibody therapies, including complement consumption and inhibition by the tumor cells. In Aim 2,
we will couple GOF-FB to proteins that bind components of the solid tumor or its microenvironment. This
approach will promote inflammation in regions in and around solid tumors and enhance local immune responses
that can ultimately eliminate tumors or resolve tissue damage. Due to the nature of GOF-FB, these molecules
will be resistant to tumor microenvironmental immune suppression mechanisms. In aim 3, we will generate
murine GOF-FB that will pave the way to translate our findings to animal models allowing for in vivo proof of
concept experiments, preclinical studies, and assessments of safety and efficacy. Our proposed work is highly
innovative and yet supported by solid literature evidence. We propose to prove in vitro that GOF-FB can have
potential as an anti-cancer therapy. These newly engineered molecules based on human complement immune
disorders could pinpoint a new class of immune modulators with greater specificity, reach, and activity than
current treatments. It represents a different direction from previous research performed in our lab, but the
expertise required to carry out the proposed work and the collaborators are already in place. Furthermore, the
proven efficacy of some FDA-approved complement inhibitors used to treat diseases caused by GOF mutations
in complement activation assures that our approach will have minimal side effects that can be readily addressed.
The work proposed here to leverage GOF mutations to identify new therapies could improve the treatment of a
myriad of severe diseases, including cancer, autoimmunity, and even infectious diseases.

Public health relevance
PROJECT NARRATIVE Gain-of-function mutations in activators of the complement system have been defined in rare genetic disorders and lead to increased inflammation and tissue damage. We propose here that engineering these mutant proteins to target specific cells or tissues will provide a new approach to driving and regulating localized complement activation and inflammation. In this application, we will generate proteins capable of directing complement activation to cancer cells with great immunotherapeutic potential.